Broadly applicable high throughput variant interpretation and validation for MYH7

Project Summary
The advancement in sequencing technology has enabled the practice of clinical diagnostic sequencing,
however, the bottle neck remains to be the correct interpretation of millions of variants identified. Despite of the
recent advances in artificial intelligence assisted variant interpretation, this is a particularly prominent problem
when the pathogenicity is associated with gain-of-function missense mutations. The overall objective of this
application is to develop a high throughput variant interpretation approach for MYH7, which will be broadly
applicable to other cardiomyopathy and genetic diseases. The central hypothesis is that MYH7 variants will lead
to gene expression profile changes, which will serve as a sensitive marker to predicting pathogenicity. In this
proposal, we will test the central hypothesis with three specific aims: 1) Develop an integrase-based system for
high throughput variant molecular phenotyping in induced pluripotent stem cell differentiated cardiomyocytes
(iPSC-CM) using single cell RNAseq and contrastive machine learning algorithms; 2) Functional validation in
iPSC-CM using cell size and contractility; 3) Detailed myofilament structure/function studies of the selected
variants for in-depth understanding of genotype-phenotype relationship. The research proposed in this
application is innovative because it takes advantage of single cell sequencing data for robust molecular
phenotyping, it will develop novel machine learning variant interpretation tools specific for structure proteins like
MYH7, and it will generate unprecedented functional experimental data of MYH7 variants in iPSC-CM, which not
only is informative in variants interpretation, but also provides amino acid level functional data on myosin that
can inform our understanding of sarcomere biology. The proposed research is significant because it will develop
a platform that enables high-throughput functional assessment of all possible variants of MYH7, which could
ultimately help to solve all current variant of unknown significance and future ones to be identified in MYH7. This
strategy is readily adaptable to all other inherited cardiomyopathies and other genetic diseases.

Public health relevance
Project Narrative The proposed research develops and validates a platform to perform functional assessment of MYH7 variants in parallel in a high throughput fashion, which will inform a contrastive machine learning model to predict additional variants. The results will be validated both by high throughput functional assays and detailed structure function study of myosin. Once completed, we will be able to ascertain pathogenicity of all current and future MYH7 variants and use this information to direct patient care; our strategy can be readily adopted to interpret other inherited cardiomyopathies and other genetic conditions.